Georgia Comprehensive Metabolomics and Proteomics Unit for MoTrPAC

PROJECT SUMMARY
The Georgia Comprehensive Metabolomics and Proteomics Unit for MoTrPAC (CMP-GA) is a cross-cutting
team with advanced high-throughput chemical analytics and big data capabilities to develop a comprehensive
map of molecular transducers of physical activity. The investigative team excels in ultrasensitive, precise and
spatially resolved analyses of small molecules, lipids, and proteins. The team members have strong academic
records as innovative, independent scientists, core laboratory directors and effective collaborators in complex
research initiatives. Instrumentation includes state-of-the-art ultra-high resolution accurate mass high-field
Orbitrap tandem mass spectrometry (MS) and ultraperformance liquid chromatography (UPLC); three-
dimensional (3-D) molecular imaging via high throughput multi-modal MS at 5 m resolution; unique ion
mobility-mass spectrometry machine-learning approaches for chemical identifications; and other such as GC-
Orbitrap, 1D and 2D high field (800 MHz) NMR spectroscopy, ICP-MS, immunoassays, chemical and
enzymatic assays, etc. The analytical laboratories are integrated through the NIH-supported Atlanta Clinical
and Translational Sciences Institute, and operate within the outstanding research environment of Emory
University and the Georgia Institute of Technology (GA Tech). CMP-GA has six elements organized to provide
1) leadership in the design and implementation of MoTrPAC goals; 2) bioinformatics, computational support
and data delivery to the MoTrPAC Data Coordinating Center; 3) global, targeted and spatially resolved
metabolomics; 4) metabolite forensics for unequivocal chemical identification of novel molecular transducers;
5) innovative proteomic and chemoproteomic technologies to define transducers within the redox proteome,
ubiquitinome, acetylome, kinome and nuclear proteome; and 6) identification and quantification of lipid
transducers. Through the successful completion of these aims and collaboration with the MoTrPAC
consortium, investigators of CMP-GA will deliver a publically-available data resource and molecular transducer
map that will enhance and accelerate mechanistic research on diseases and conditions affected by physical
activity.

Public health relevance
PROJECT NARRATIVE This is a comprehensive metabolomics and proteomics chemical analysis site to support the Molecular Transducers of Physical Activity Consortium (MoTrPAC). Advanced analytical methods, including mass spectrometry, bioinformatics and chemical forensics are used to provide targeted and global analysis of small molecules, lipids, proteins to develop a molecular transducer map for physical activity.